Leveraging CD26high Meso-CAR T cells in patients with advanced pancreatic cancer

PROJECT SUMMARY
This project translates an innovative, chimeric antigen receptor (CAR) T cell therapy to patients with pancreatic
ductal adenocarcinoma (PDAC). We posit efficacy of CAR T targeting mesothelin (relevant PDAC antigen) can be
enhanced by use of 1) a new subset expressing CD26 (a costimulatory molecule with enzymatic properties) termed CD26+
T cells; and 2) an innovative expansion protocol that incorporates the phosphatidyl inositol kinase-3 inhibitor
(PI3Ki), duvelisib to improve CART persistence and metabolism. Our team reported that CD26+CD4+ T cells
redirected with a Meso-CAR were polyfunctional and elicit activity against PDAC tumors in mice. Our overall
hypothesis is that PI3Ki-expanded, CD26+CD4+ T cells are an ideal template for safely redirecting
immunity to PDAC. While CD26+CD4+ T cells are polyfunctional, they fully differentiate after expansion, which
reduces potency. However, our data shows CD26+T cell differentiation can be reduced using duvelisib during
manufacturing, thus sustaining self-renewal (i.e., “stemness”), while enhancing in vivo cytolytic activity against
orthotopic KPC tumors. This Project pursues three specific aims. Aim 1 will test our hypothesis that CD26+CD4+
CAR T cells degrade chemokines that induce suppressive myeloid cells, favorably altering the cell composition
in the tumor microenvironment using relevant murine PDAC models (orthotopic and metastatic) in immune competent
mice. Functional impact of Meso-CAR T on endogenous T cells will be tested in parallel studies in RAG2 KO to
further define mechanism of efficacy. Aim 2 will investigate the interaction between Duvelisib-expanded
CD26+CD4+ CAR T cells and conventional CAR T cells in targeting PDAC. Also, the role of CD26 in efficacy will
be evaluated by using CD26+CD4+ MesoCAR T cells expressing enzymatically active or inactive CD26 or treating
mice with a selective CD26 inhibitor (sitagliptin). The effect of CD26 enzyme modulation on the recruitment of
myeloid cells in the PDAC TME will be tested in both human and murine in vivo systems. In Aim 3, we conduct
a novel first-in-human trial in patients with advanced PDAC to evaluate safety, persistence, and fate of co-infused
Duvelisib-expanded CD26+CD4+ and conventional CD3+ Meso CAR T cells. We will refine manufacturing and
generate foundational feasibility/reproducible CMC data for an IND application. A phase 0/1 clinical trial will use
low dose numbers of Duvelisib-expanded CD26+CD4+ Meso-CAR T cells, followed by dose escalation of
Duvelisib-expanded CD26+CD4+ Meso-CAR T cells in combination with differentially bar-coded conventional
CD3+ Meso-CAR T cells to define safety and clinically effective dose of this novel ACT therapy. Engraftment and
persistence of CAR T products in blood and patient tumor biopsies will be tested with spatial molecular imaging
and multi-parameter flow cytometry to study CART's metabolic/effector properties. Collectively, this work will
define properties of novel Duvelisib-expanded CD26+CD4+ CAR T cells in animal PDAC models and determine
safety and persistence of CD26+CD4+ CAR T cells in patients. Our results will enable subsequent trials with
CD26+CD4+ Meso-CAR T cells as an individual therapy or a component of combined cell therapy in PDAC.

Public health relevance
Project Narrative In this application we address the overall hypothesis that a novel population of T cells expressing a protein on their surface termed “CD26” are ideal template to modify and use as a cell therapy for pancreatic cancer. Using a series of experimental models, we will study how the unique properties of these cells allow them to work when administered on their own, and together with other more conventional T cells that are engineered to recognize, mesothelin, a marker present on pancreatic cancer cells. Our team will next conduct a first in human clinical trial in patients with pancreatic cancer to ensure these cells are safe and obtain tumor biopsies and blood samples to understand their fate in pancreatic cancer patients.